Behavioral paradigms for cognitive neuroscience in the common marmoset

SUMMARY/ABSTRACT
Primates including humans evolved remarkable visual and cognitive functions compared to other mammals
making it essential to utilize primate models specifically for studying high-level brain function. The common
marmoset is one emerging primate model that holds immense experimental promise because of its small size
(similar body size to a rat) and flat, surface-accessible cortex as opposed to most other monkey models which
are significantly larger with highly folded brains. There remains concern, however, about the cognitive abilities
of such a small monkey, such that there is a clear need for demonstrating marmoset high-level behavioral
performance before studying brain circuits in marmosets. In this proposal, we directly address this overriding
concern in the field by prescribing sophisticated task paradigms for the marmoset, addressing barriers to the
marmoset’s widespread adoption in systems neuroscience. In Aim 1, we study cognitive flexibility by developing
a rule-learning task that abstracts from the number and identity of visual items being compared. In Aim 2, we
use a virtual foraging paradigm to study 3D visuospatial inference where marmosets have to recall high versus
low value targets, predicting their locations from novel viewpoints. In both aims, we efficiently develop task
paradigms using touchscreens in their housing unit, and then we subsequently validate in-lab performance using
eye tracking under head-fixed conditions suitable for neuroscience experiments. Advancing the marmoset model
in the field of cognitive neuroscience will lead to future inquiries elucidating neural mechanisms in high-level
brain areas such as frontal cortex and the hippocampus and have implications for understanding cognitive
impairments of visual memory and spatial navigation common to neurodegenerative diseases.

Public health relevance
PROJECT NARRATIVE Small animal models confer great advantages in efficiency and accessibility for experimental neuroscience; however, few options are available for studying high-level brain function as small animals like rodents lack many of the brain areas and cognitive flexibility found in monkeys and humans. Here, we develop behavioral paradigms to facilitate the use of the common marmoset, a small monkey model, in high-level sensory and cognitive neuroscience. These behavioral paradigms provide phenotypes for neural studies in healthy, aged, and diseased marmoset brains with long-term implications for understanding early cognitive impairments in Alzheimer’s disease and related dementias.